Stanford Cancer Institute

PROJECT SUMMARY – OVERALL
The Stanford Cancer Institute (SCI) is an NCI-Designated Comprehensive Cancer Center that integrates key
strengths in cancer biology, immunology, genetics, population sciences and clinical oncology with expertise in
imaging, engineering and technology development. The translation of basic science discoveries through clinical
trials and collaborative team science is a distinguishing feature of the SCI.
The SCI has 300 members and includes faculty from 32 Departments and from three Schools (Medicine,
Engineering, and Humanities and Sciences) within Stanford University. Seven programs (Cancer Biology and
Cancer Stem Cells, Cancer Imaging and Early Detection, Cancer Immunotherapy, Cancer Therapeutics,
Hematologic Malignancies, Population Sciences, and Radiation Biology) address basic, translational, clinical,
and population-based components of cancer research and are supported by 11 shared resources (Animal Tumor
Models, Biomedical Informatics, Bioscience Screening, Biostatistics, Cancer Imaging, Cell Science Imaging,
Flow Cytometry, Genomics, Human Immune Monitoring, Proteomics, and Tissue Procurement).
With a current NCI funding base of $41.9 million, $33 million in other cancer-related NIH support, $16.4 million
in other peer-reviewed cancer-relevant funding and $91.3 million in total peer reviewed funds, the SCI is fulfilling
its mission to translate Stanford discoveries into improving the diagnosis, treatment, and outcomes of cancer
patients and to better understand cancer etiologies among diverse populations in the Bay Area and beyond. SCI
has made major investments in Population Sciences, including the recruitment of a new Associate Director for
Population Sciences and the formation of a new Department of Epidemiology and Population Health. We have
brought important focus to our catchment area and to health equity through the recruitment of a new Associate
Director for Community Outreach and Engagement and the formation of a new SCI Office of Cancer Health
Equity and Community Engagement. SCI has developed a highly successful clinical and translational effort in
CAR-T therapies bringing new treatments to our patients. Finally, SCI has begun a major initiative in cancer drug
discovery uniting cancer scientists, cancer physicians, chemists and engineers across the Stanford campus in
their efforts to develop new cancer therapeutics.
The SCI, under the new leadership of Steven Artandi, MD, PhD, is requesting CCSG support from the NCI for
its critical activities, including in Community Outreach and Engagement, Shared Resources, Cancer Research
Training and Education Coordination, Clinical Protocol and Data Management, Protocol Review and Monitoring,
Program Leadership, Administration, and Developmental Funds. With new and talented additions to the senior
leadership, many new recruitments, and highly effective collaborative interactions, the SCI is poised to further
accelerate its contributions to cancer research in the next funding period.

Public health relevance
PROJECT NARRATIVE – OVERALL The Stanford Cancer Institute (SCI) brings together researchers from across Stanford University with the goals of improving cancer prevention, detection, diagnosis, treatment, and outcomes for individuals and for populations, both within our region and in the world at large. The SCI has a compelling history of cancer discovery that has accelerated with the development of innovative new technologies, a strong focus on understanding the etiologies of cancers in individuals and in populations, a proven track record in implementing high impact clinical trials and a mission to translate findings to improve the care of cancer patients. With the support of the Cancer Center Support Grant, the SCI makes major contributions across the spectrum of research from basic discovery through clinical application to the population sciences that will enhance our understanding of disease processes, bring new diagnostic and therapeutic modalities to patients, facilitate risk assessment and prevention, and improve the overall outlook for individuals afflicted with or at risk for cancer.